NNLM All of Us Program Center

The proposed “Network of the National Library of Medicine (NNLM) All of Us Program Center (NAPC)” will
leverage a multi-year history of productive collaboration between two primary institutions, the University of
Pittsburgh and the University of Iowa, to employ an enhanced “team science” approach to address the
community engagement, training, and education needs of the NNLM All of Us Program. The NAPC serves a
critical role in coordinating engagement, programs, partnerships, activities, and training offered by NNLM in
support of the NIH All of Us Research Program. NAPC will develop and distribute a robust portfolio of
community-based programs and services, create opportunities for national and regional engagement, and build
relationships within NNLM and the All of Us Ecosystem. In doing so NAPC ensures that NNLM members can
build capacity to improve health, digital, and research literacy in their communities, and that individuals,
particularly populations underrepresented in biomedical research (UBR), will have access to the knowledge,
resources, and skills necessary to understand precision medicine and participate in All of Us.
As previous NNLM All of Us pilot program awardees, the University of Pittsburgh and the University of Iowa
bring a unique understanding of the complexity of the program, quality and experienced personnel, and
existing professional relationships with NNLM, the All of Us Ecosystem, public libraries, and community
organizations. Together, these two institutions will create a dynamic and collaborative research environment,
provide high-quality innovative program deliverables, and implement innovative workflows, mechanisms, and
initiatives to grow the NNLM All of Us Program. The NAPC will continue to build on the work of the NNLM All of
Us pilot by using data-informed methods and tools to identify new opportunities to reach diverse communities
and organizations with little previous engagement. We will increase capacity, programming, and engagement
opportunities around health, digital, and research literacy. We will continue to assess and support the training
and education needs of the All of Us consortium and advance the science of engagement, community-based
participatory research, and human-centered design through training, publications, presentations, and other
modes of dissemination so that others can incorporate NAPC best practices into their training and community
engagement programs.
The NAPC has three overarching aims to accomplish the goals of the NNLM All of Us Program:
1. Increase All of Us learning options for a wide variety of audiences in cooperation with community partners,
NNLM, the All of Us Consortium Training Board, and the All of Us Ecosystem.
2. Raise awareness of and interest in All of Us.
3. Build capacity to improve the public’s knowledge, resources, and skills to make informed decisions about
health, contribute to research, and engage with digital health information and research.

Public health relevance
Health, digital and research literacy focus on ensuring that individuals have the knowledge, resources and skills necessary to make informed decisions about their health, how they can contribute to research, and how to engage with health information and research in a digital environment. By developing and distributing community-based programs and services around these topics and helping communities understand Precision Medicine, the work of the NAPC will improve public health and increase awareness of the All of Us Research Program, which will in turn increase public interest and participation, and support the program’s goals to diversify biomedical research data and advance individualized healthcare.